IGF::OT::IGF CEDARS-SINAI MEDICAL CENTER:1110239 [19-029097]. TISSUE SOURCE SITE (TSS)FOR NCI'S CLINICAL PROTEOMIC TUMOR ANALYSIS CONSORTIUM (CPTAC) CASES ELIGIBLE FOR PAYMENT 4.

The contractor collected biospecimens included tumor tissue, normal tissue, and blood according to an NCI-provided protocol. The biospecimens were used for proteogenomic characterization studies. The contractor collected corresponding clinical data including medical history, demographic information, diagnostic data, and annual follow-up reports.